Optimizing MERFISH to allow multiplexed measurement of developmental and tonotopicgene expression gradients in the cochlea

PROJECT SUMMARY
The adult cochlea presents many technical hurdles to researchers studying the normal function of its
constituent cell types, and how these cell types respond to injury, aging and degeneration. Because the
cochlea is encased in strong bone and contains relatively small numbers of cells compared to other sensory
organs such as the retina, isolating cells to characterize their structure, physiology or gene expression is
challenging. Moreover, histological methods to make the cochlea more accessible, such as decalcification, are
harsh treatments that can degrade mRNA or protein. In this pilot R21 proposal, we will assess the feasibility of
a recently-developed technique known as MERFISH – Multiplexed Error-Robust Fluorescence In Situ
Hybridization – to simultaneously detect and quantify the expression of hundreds of genes in the cochlea. We
believe this technique is sensitive enough to reveal quantitative differences in gene expression along the
developmental and tonotopic gradients that exist along the basal-apical axis of the cochlea. Developing a
robust protocol to detect, quantify and spatially localize hundreds of genes at once has the ability to transform
our understanding of the normal function of the cochlea, and how gene expression changes in the cochlea and
spiral ganglion after noise exposure, hair cell loss, aging and drug administration. The goal of this proposal is
to demonstrate the feasibility of MERFISH in the neonatal and adult cochlea and to develop protocols to allow
MERFISH to be used by the hearing and balance community.

Public health relevance
PROJECT NARRATIVE It has historically been very hard to perform measurements and experiments on the adult cochlea, as it is a structure of extreme mechanical sensitivity and delicacy, contains relatively small numbers of cells, and is encased in the strongest bone in the body. This proposal seeks to overcome these limitations by using a new technique, MERFISH to directly measure the expression of genes in the different cell types of the cochlea. This technique may shed light on how the cochlea is able to respond to different sound frequencies, and how different regions of the cochlea respond to injury and age-related degeneration.